Campaigns and Monitoring Period of Performance 09/19/2016 - 09/18/2017

National Cancer Institute (NCI) has developed smoking cessation services for multiple population groups and diverse audiences. NCI needs to provide core support for the content and on-line resources to effectively reach and monitor engagement as well as to deliver mHealth interventions within these populations and audiences.